mRNA vaccine responses in PLWH

Project Summary
Two mRNA COVID vaccines that have greater than 90% efficacy in healthy donors have
been developed. However the efficacy of these vaccines in PLWH is unknown. PLWH
have had suboptimal responses to some prior vaccines potentially because they make
limited naïve T cell responses. We and others have shown T cell cross-recognition of
spike proteins from SARS-CoV-2 and the common cold coronavirus and demonstrated
that these cross-reactive responses are less effective against SARS-CoV-2 than mono-
reactive responses. We hypothesize that cross-reactive memory responses will
contribute more towards the total SARS-CoV-2 responses in PLWH than in healthy
donors and this will result in less effective responses to the mRNA vaccines. We will test
this hypothesis by comparing CD4+ T cell and antibody responses in vaccinated healthy
donors and PLWH. Our results will have major implications for future policies regarding
booster shots for PLWH and the general population

Public health relevance
Project Narrative Two mRNA COVID vaccines have been recently developed. While they have been shown to be very effective in healthy donors, it is unclear how effective they will be in PLWH. In this study we will compare T cell and antibody responses in healthy donors and PLWH who have received mRNA vaccination.